PCE contaminated drinking water &disorders of reproduction &development

Tetrachloroethylene (also called perchlorethylene or PCE) is a solvent commonly used for metal degreasing, textile processing, and dry cleaning. Studies on the risk of reproductive and developmental toxicity associated with PCE exposure have shown adverse effects among animals and humans. The proposed epidemiologic study will test the hypothesis that PCE found in the distributions systems of public drinking water supplies in the Cape Cod region of Massachusetts is associated with the following reproductive and developmental outcomes: sperm and menstrual abnormalities, impaired fecundity, secondary infertility, spontaneous abortion, low birth weight, intrauterine growth retardation, congenital malformations, and developmental disorders of learning and attention. This will be accomplished by conducting a population-based retrospective cohort study including approximately 2,200 Cape Cod children and their families who were exposed to PCE-contaminated drinking water and a comparable group of 2,200 unexposed children and their families. Families will be identified using Massachusetts birth records from 1968 through 1983. During this period, tens of thousands of Cape Cod residents were exposed to PCE when it leached from the vinyl lining of asbestos cement drinking water pipes. Families in the exposed group will include at least one child with prenatal and varying amounts of postnatal PCE exposure, and mothers and fathers with exposures during their reproductive years. Cohort family members will be traced, and mothers will be interviewed to obtain information on reproductive and developmental abnormalities, confounding variables, and residential histories. Reports of abnormalities will be verified by record review. Buccal swabs will be sought from mothers for later testing for susceptibility biomarkers by molecular methods. Exposure to PCE- contaminated drinking water will be estimated using an exposure model and geographic information system (GIS) database developed for our current Superfund Basic Research Center. The relative risk of each adverse outcome will be calculated in relation to PCE exposure while controlling for confounding variables. The impact of water use and breast feeding practices will be taken into account.